Synthetic Biology Platforms for Natural Product Discovery and Biosynthesis

DESCRIPTION Abstract: Natural products and compounds derived from or inspired by natural products make up a large fraction of drug molecules. Traditional synthesis strategies based on recovery from the natural source and chemical synthesis approaches present many challenges associated with the purity, scale, and complexity of the compounds, contributing to the raising costs and reduced number of new drug molecules. The development of scalable manufacturing platforms for natural product synthesis will address many challenges faced between natural product drug discovery and therapeutic application. The engineering of biosynthetic pathways in microbial hosts represents a newer approach to chemical synthesis with exciting potential. However, current approaches in metabolic pathway engineering require a significant investment in time and resources and do not scale with the complexity and breadth represented in natural product biosynthesis pathways. As such, for many natural products of interest, microbial biosynthesis strategies are currently viewed as impossible. The goal of the proposed project is to develop synthetic biology platforms that will dramatically advance the application of cellular biosynthesis strategies to natural product drug discovery, development, and production. The scale and efficiency of manufacturing processes that can be engineered into microbial systems will be transformed through the development of new approaches that will enable the implementation of key biosynthesis process optimization strategies. In particular, the project will pioneer and apply the following approaches: (i) noninvasive and real-time detection of metabolite levels, (ii) closed loop embedded control of biosynthesis system behavior, (iii) active organelle routing supporting biosynthesis specialization and compartmentalization; and (iv) high- throughput screening methods for discovery of new biosynthetic activities within a microbial chassis. The power of these new approaches will be demonst

Public health relevance
The broad goal of this research is to develop synthetic biology platforms that will dramatically advance cellular biosynthesis strategies for natural product drug discovery, development, and production. By providing scalable manufacturing platforms, the proposed research will transform the way in which the development and manufacturing of drugs is universally approached. These new approaches will be developed and validated on the medicinal benzylisoquinoline alkaoids, an important class of plant secondary metabolites that exhibit diverse activities, including antiviral, antiprotozoan, antibacterial, and antineoplastic activities, and activities for treating cardiovascular and autoimmune diseases.